Allostatic Load in Latino Youth (ALLY) study: The Role of Discrimination and Environmental Racism

PROJECT SUMMARY
It is estimated that by 2050, Latino/a/x will compose over half of the California population, highlighting the
critical priority for understanding cardiometabolic health risk in this population. Latinx have a 50% lifetime risk
of developing type 2 diabetes and other chronic diseases, a result of a complex mixture of predisposition,
health behaviors, and environmental factors. A common physiological mechanism associated to chronic
diseases is a failure to maintain homeostasis during times of persistent stress. While ample evidence supports
a role of psychosocial stressors on allostatic load, several important challenges have not been yet addressed
in Latinx youth, such as the role of racial/ethnic discrimination; therefore there is an urgent need to examine
the impact of racial discrimination along with wide-ranging profiles of psychosocial and environmental
stressors, in-depth phenotyping of allostatic load, and pertinent biomarkers to identify subsets of high
cardiometabolic disease risk individuals. The overarching aim of this proposal is to characterize allostatic load
(the result of cumulative stressors on physiology via alterations in brain or nervous system physiology)
associated with socio-environmental stressors focused on perceived and imposed (environmental) racial
discrimination in Latinx youth. We will leverage a body of literature specific to Los Angeles area Latinx youth to
develop an evidence-based allostatic load index and to determine the role of racism, alongside other salient
predictors of allostatic load. To test our aims, we will collect two separate waves of data (2-years apart) from
the same subjects, Latinx or White, late adolescents/young adults. Data collection will consist of serum and
saliva biospecimens for determination of allostatic load indices. A comprehensive panel of 20 allostatic load
makers will be utilized representing neuroendocrine, cardiovascular and metabolic components, markers that
were specifically selected based on existing literature on allostatic load and knowledge on pathophysiology
associated with type 2 diabetes risk in Latinx youth. Additional measures include a cumulative measure of
environmental burden (as determined by CalEnviroScreen 4.0), and comprehensive measures of
discrimination, psychosocial stress, and health history and behaviors (family history of type 2 diabetes, diet,
physical activity, smoking, and sleep). To our knowledge, this will be the first longitudinal study in Latinx vs.
White youth specifically designed to characterize allostatic load profiles and to examine the role of racial/ethnic
discrimination.

Public health relevance
PROJECT NARRATIVE This interdisciplinary research will provide a better understanding of the relationship between social determinants and biological mechanisms during the transitional period of late adolescence to young adulthood. Our findings could have strong implications for social justice measures as well as public health interventions to curb cardiometabolic disease. By studying interpersonal discrimination and the results of environmental racism as stressors, we begin to deconstruct the psychosocial and physical costs of allostatic load for Latinx youth so that future interventions will be approached not only from an individual, but also at a systemic level.